The role of indole-induced immune dysregulation in collagen-inducedarthritis

Project Summary/Abstract
Pre-clinical Rheumatoid Arthritis (RA) is a period in which systemic autoimmunity develops in the years prior to
onset of clinically apparent disease. Here, we aim to define the mechanisms leading to pre-clinical autoimmunity,
which could inform the design of therapies to block these pathways and prevent RA. Our group has been integral
in identifying and investigating the “mucosal origins” hypothesis of RA, utilizing the collagen-induced arthritis
(CIA) model to demonstrate the requirement of the microbiome for disease development. We recently identified
a bacterial-derived tryptophan metabolite, indole, as a key regulator of autoimmunity in this model. Depletion of
either the microbiome (using broad-spectrum antibiotics) or dietary tryptophan is protective against CIA, and
supplementation with indole in either setting reverses this protection. This indole-CIA model provides, for the first
time, a model in which a single bacterial metabolite is sufficient for disease development. Based on our
preliminary findings that Th17 cells and inflammatory cytokine production (especially IL-6) are elevated in this
indole-CIA model, I hypothesize that indole is a bioactive metabolite that promotes CIA by skewing Th17 cell
differentiation and stimulating antigen presenting cells (APCs) to produce IL-6. The experiments outlined in this
proposal are designed to define the effects of indole on CIA. Aim 1 will determine the effect of indole on CD4
effector T cell responses, both in the indole-CIA model and in a model of antigen-specific T cell responses
utilizing OT-II transgenic mice. Aim 2 will then identify the source of and requirement for indole-mediated IL-6
production. I will utilize combined single cell RNA/ATACseq to identify the cell subsets and signaling pathways
in which indole induces IL-6 production. Finally, I will test the requirement for dendritic cell (DC)-mediated IL-6
production in indole-CIA. Successful completion of these aims will (1) define the cell subsets and functions
affected by indole in the indole-CIA model, which will allow for future mechanistic studies to better define and
modulate this process, (2) define the role of DC-derived IL-6 in CIA, which has never been shown, and (3)
generate hypotheses to later identify the signaling pathways affected by indole stimulation, which will be
necessary to understand the mechanisms by which indole incites autoimmunity. Altogether, these findings will
fill a critical knowledge gap regarding the role of the microbiome in the development of inflammatory arthritis.
Furthermore, through these studies I will become an expert in mucosal immunology, learn to design and test
rigorous hypotheses, and become proficient in cutting-edge bioinformatic techniques through analysis of the
RNA/ATACseq data generated in Aim 2. The training gained through this proposal will enable me to be well-
positioned for a research fellowship in rheumatology and apply skills needed for a successful K08 in the future.

Public health relevance
Project Narrative Pre-clinical Rheumatoid Arthritis (RA) is a period in which systemic autoimmunity develops in the years prior to onset of clinically apparent disease, which provides a window to intervene. While intestinal dysbiosis and altered tryptophan metabolism have been observed both in murine models of autoimmunity and in patients with rheumatic diseases, the mechanisms by which the microbiome and tryptophan metabolites may contribute to immune dysregulation have not been defined. Elucidating these mechanisms may therefore inform the development of future therapies to precisely target and/or modulate these pathways during pre-clinical RA.